T-cell plasticity mediating treatment resistance and side effects in atopic dermatitis

PROJECT SUMMARY
Type 2 inflammation is mediated by a specific branch of the immune system, assumed to have developed as a
major defense mechanism against parasitic infections and infestations. However, in our modern lifestyle, this
kind of immune axis is mostly encountered in the context of pathological activation, especially in inflammatory
diseases such as atopic dermatitis (AD). Consistently, the type 2 blocking antibody dupilumab was the first
targeted FDA-approved treatment for AD. However, only 50% of patients achieved a 75% improvement in their
skin scores upon dupilumab treatment during phase III clinical trials, and 10% even develop de novo paradoxical
inflammatory side effects such as blepharitis, conjunctivitis, psoriasiform rashes, or a specific form of dupilumab-
associated head/neck dermatitis (DAHND). Until today, mechanisms underlying treatment resistance and
paradoxical inflammatory side effects of dupilumab treatment remain only insufficiently understood. Thus, there
is an urgent need to correct this knowledge gap for the development of better treatment modalities for AD.
Preliminary data from our group show increases in type 1 and type 22 immune signatures in dupilumab non-
responders at baseline and throughout treatment. In addition, we find oligoclonal expansion of cytotoxic type 22
T cells in biopsies of DAHND. Interestingly, these cells showed overlapping features with type 2 cells, suggesting
a considerable degree of inflammatory T cell plasticity, or transdifferentiation, both in dupilumab-resistant AD
and in DAHND. In this proposal, we will utilize human skin biopsies from dupilumab-treated AD patients to study
cellular and molecular features of the immune microenvironment in resolving (dupilumab responders), stable
(dupilumab non-responders) and paradoxically flaring skin lesions (DAHND and psoriasiform rashes) through
high-throughput techniques including single-cell RNA-seq, single-cell ATAC, and spatial transcriptomics. T cells
isolated from these lesions will be studied in in vitro cultures and in skin spheroid models to better characterize
their cytokine production behavior over time, as well as their crosstalk with cells of the tissue microenvironment,
respectively. The rationale for this proposal is that once it is understood how type 2 cells are regulated in AD
during individual treatment responses, these mechanisms can be utilized to create effective and novel stratified
therapies for AD.

Public health relevance
PROJECT NARRATIVE Type 2 inflammation is the basis for numerous human skin diseases such as atopic dermatitis (AD), with a high disability rank and a strong negative impact on disease-related quality of life. While type 2 blockade with the therapeutic antibody dupilumab is an approved treatment modality in AD, only a subset of patients shows complete skin clearance, and about 10% even develop paradoxical proinflammatory side effects. In this proposal, we seek to study treatment-resistant AD as well as paradoxical inflammatory skin side effects in patients treated with dupilumab to increase our understanding of underlying mechanisms and to help develop better treatment modalities for patients affected by this debilitating, chronic skin condition.